Research Support Core D: Clinical and Behavioral Services

Project Summary Core D – Clinical and Behavioral Services Core
The Clinical and Behavioral Services Core D furthers the scientific mission of the Case
Western Reserve University Center for Excellence on the Impact of Substance Use on
HIV by providing a uniform, broadly available resource to gain access to subjects, specimens,
and collected data for basic, translational, clinical, epidemiological, behavioral, and psychosocial
studies of HIV disease. Currently, the Core has a searchable registry with longitudinal history of
virtually all HIV-infected patients followed in the MetroHealth System (MHS) ID clinic, the largest
HIV provider in Northeast Ohio, and will establish a biorepository linked to this clinical data.
Core D will enable investigators to conduct studies that require access to populations that are
typically difficult to reach, recruit, and retain. The Database will leverage the robust electronic
health record (EHR) that has been in place since 1999 at MHS. The EHR has embedded search
tools to (i) enable population health research, (ii) identify subjects for research and registries,
(iii) track populations, and (iv) retrieve extensive clinical information with data extending back to
1999. The Specimen Repository will be linked to the Database and offers researchers ready
access to stored samples complete with comprehensive, longitudinal, clinical, patient reported
outcomes, behavioral, and laboratory data. Core D will leverage existing studies of patients who
use illicit substances to develop a comprehensive database and specimen repository of persons
with substance use disorder and HIV and then expand to include HIV-negative at-risk for HIV
substance using individuals. The linked repository will include a robust expansive program for
longitudinal semi-annual collection of peripheral blood mononuclear cells, plasma, serum, stool,
rectal swabs, vaginal swabs, and urine. The repository will also collect and store tonsillar tissue,
CSF, and colonic biopsies. Participants will receive client centered assistance to treat addiction
from staff trained to use motivational interviewing. Core D will integrate public and mental health
activities in Northeast Ohio regarding persons with HIV and Substance Use Disorder through
clinical and community outreach with our neighboring public and mental health organizations,
that include urban (Cleveland), suburban (Cuyahoga), and suburban/rural (Lorain) populations.
Finally, Core D leadership will assist investigators in formulating research questions that take
full advantage of the clinical Database and specimen Repository, while avoiding pitfalls and
potential biases that result from incomplete understanding of the data structure, patient-related
data, and patient characteristics.

Public health relevance
Project Narrative - Clinical and Behavioral Services Core D Our understanding of the impact of substance use on HIV and those at-risk for HIV is limited by access to patients in this extremely vulnerable and marginalized population. The Clinical and Behavioral Services Research Support Core D’s activities will create, maintain, and expand a Clinical Database and Specimen Repository of this population to enable researchers the opportunity to complete translational investigations on difficult to reach and retain populations. The Clinical database, as well as their biological samples, will initially include HIV substance using individuals and then expand to include at-risk HIV negative substance using individuals.